Scalable Technologies for the Assessment and Rescue of Brain Health: Brain-START

PROJECT SUMMARY
Alzheimer's Disease and Related Dementias (ADRD) disproportionately affect low- and middle-
income countries (LMICs), where approximately 60% of cases reside. Current diagnostic
approaches, primarily developed in high-income countries, have not been validated in LMIC
settings, where unique sociocultural and linguistic characteristics affect test performance and
interpretation. Additionally, the performance characteristics of blood-based biomarkers for
Alzheimer's disease (AD-BBMs) remain unknown in genetically heterogeneous populations like
Kenya and Pakistan, creating a critical barrier to early and accurate detection. The study has
three specific aims: (1) Validate an integrated ADRD detection toolkit against gold-standard
measures (CSF and FDG-PET) in urban hospital settings (N=300); (2) Implement and evaluate
the toolkit in rural community clinics using a task-shifting approach (N=1,000 in Kenya; N=200
pilot in Pakistan); and (3) Develop population-specific risk assessment models incorporating
traditional and LMIC-specific risk factors. The research design employs a mixed-methods
approach combining clinical validation, implementation science, and advanced analytics. For
Aim 1, we will recruit participants through hospital-based referral networks and community
outreach, collecting comprehensive cognitive, biomarker, and clinical data. The toolkit features
first-of-its-kind digital speech analysis that captures acoustic features robust to the unique
language use patterns of multilingual participants. This is integrated with multi-domain digital
cognitive assessment targeting memory, executive function, and visuospatial abilities to support
differential diagnosis of ADRD subtypes. The toolkit also includes olfactory testing and AD-
BBMs (plasma Aβ42/40 and p-tau217), with establishment of the first reference standards for
these biomarkers in East African and South Asian populations. Aim 2 implements a two-stage
assessment strategy in rural settings, with initial screening by community health workers
followed by comprehensive evaluation of screen-positive cases. Implementation outcomes will
be evaluated using the RE-AIM framework. Aim 3 applies machine learning techniques to
identify novel risk factors and interaction effects specific to LMIC populations. This work will
generate new knowledge about the adaptation requirements for valid ADRD assessment in
multilingual populations, establish region-specific biomarker reference standards, and develop
implementation frameworks for resource-limited settings. Results will inform strategies for
serving similar populations globally, including resource-limited communities in high-income
countries, through validated early detection tools, population-specific risk assessment models,
and healthcare delivery frameworks utilizing task-shifting approaches.

Public health relevance
PROJECT NARRATIVE Worldwide, approximately 60% of people with Alzheimer's disease and related dementias (ADRD) live in low- and middle-income countries (LMICs), a proportion expected to increase to 71% by 2050. Current diagnostic tools for ADRD have limited validity in LMICs. This project will validate digital cognitive assessments and blood-based biomarkers for early detection of ADRD in Kenya and Pakistan, scale these tools to rural settings, and identify population-specific risk factors. Findings will improve early detection of ADRD globally, particularly in resource-limited settings and populations, including underserved communities in the United States.